Upper Airway Microbial Development During the First Year of Life

PROJECT SUMMARY
Dr. Kloepfer joined Indiana University School of Medicine (IUSM) as an assistant professor of Pediatrics
as a tenure-track research scientist. Shortly after joining the IUSM faculty, she was awarded the departmental
K12 Child Health Research Career Development Award from the Eunice Kennedy Shriver National Institute of
Child Health and Human Development. During her time on the K12, she has: 1) compiled a four member panel
to provide mentorship as she works towards independence; 2) established a relationship with IUSM Obstetrics
department to recruit from two campus hospitals and multiple outpatient clinics; 3) obtained IRB approval for the
proposed study; 4) developed her lab in the Translational Research and Integrated Biology Lab (TRIB) facility
housed within the Children’s Clinical Research Center (CCRC); 5) hired a clinical study coordinator and
laboratory technician ; 6) established a collaboration with Dr. Douglas Rusch, an informatics expert in the Center
for Genomics and Bioinformatics (CGB), an Indiana Clinical and Translational Sciences Institute (ICTSI) core;
7) successfully recruited 63 newborns for the proposed study; and 8) presented abstracts detailing preliminary
data included in the attached proposal at the May 2015 and 2016 American Thoracic Society (ATS) meeting.
During fellowship, Dr. Kloepfer became interested in the influence of airway bacteria on airway
development. Dr. Kloepfer’s preliminary data demonstrates that decreased bacterial diversity in the airway at
three months of age is associated with increased expression of IL-33 and IL-5, and wheeze by six months of
age, suggesting that decreased bacterial diversity, cytokine changes and lung function changes occur prior to 3
months of age. 16S rRNA sequencing has not been utilized to prospectively follow newborns with sampling
starting at birth. Because the prevalence of asthma continues to increase every year (currently 10% of the
population), the etiology of asthma development needs further delineation, particularly in the developing airway
prior to an asthma diagnosis. Therefore, to address the above questions, the attached proposal is designed to
investigate if airway dysbiosis precedes, coincides with, or follows changes in airway cytokines and lung function
in children who develop wheeze.
This project was developed to align with Dr. Kloepfer’s long-term research goals. They include:
determining how bacterial metabolites produced from the bacteria identified in the attached study cause airway
inflammation; and translating this research into clinically relevant prevention and intervention strategies for
children who develop recurrent wheeze and asthma. As we enter the era of personalized medicine, the influence
of bacteria on immune development and airway function must be elucidated before methods of prevention and
treatment can be prescribed and/or designed.

Public health relevance
PROJECT NARRATIVE This project is important to public health because the prevalence of asthma continues to rise and methods to prevent asthma development are desperately needed. This projects utilizes newer methods of detecting bacteria to determine if during the first year of life, infants with abnormal levels of bacteria in their airway also make small proteins that signal the airway to swell. Airway bacteria in the infant airway will also be compared with airway tests and episodes of wheezing to determine if early changes in airway bacteria lead to recurrent wheeze, which increases the chance the infant will develop asthma.